Molecular Tumorigenesis of Bladder Cancer

Summary
Bladder cancer is comprised of two major variants: low-grade papillary tumors and high-grade muscle-invasive
tumors. Although the majority of the low-grade papillary tumors are slow-growing, approximately 1 in 5 of these
tumors progresses to the stage of muscle invasion in a presently unpredictable manner. This is the principal
reason of why low-grade papillary bladder tumors require lifelong, vigilant follow-up with repeated cystoscopy
and biopsy and why bladder cancer is the most expensive cancer to treat. The genetic causes underlying the
transition from low-grade papillary bladder tumors to high-grade invasive bladder tumors have not been
delineated. Under the auspices of our parent P01 grant, we recently found that ablation of tumor suppressors
residing on human chromosome 9p21, which occurs frequently in human muscle-invasive bladder tumors, in
mice accelerates the formation of HRas-induced low-grade papillary bladder tumors, but failed to trigger
invasion. Our results suggest that loss of additional genetic components on 9p21 is necessary in order for the
invasion to take place. The objective of this administrative supplement is to request funds to support the
development of a novel transgenic line that lacks gene components additional to what we initially proposed to
investigate. The requested research supplement is well within the general scope of our parent P01 grant, and
the new mouse line will serve to accelerate the research contained in all the component projects of the parent
P01 grant. Additionally, the mouse line has the potential to facilitate the investigation of other cancer types in
which 9p21 is frequently deleted.

Public health relevance
Narrative Bladder cancer is highly prevalent and clinically challenging. The development of a novel transgenic mouse line lacking critical tumor suppressor genes on human 9p21 locus, which is deleted in a great majority of human bladder cancer, should significantly facilitate the investigation of how bladder cancer arises and progresses. Information gleaned from such investigation should also help improve the diagnosis, prognostication and treatment of bladder cancer.